Multiplexing Quantitative Photostable Nanoscopy for Single Live Cell Imaging

Project Summary (Abstract)
Multiplexing Quantitative Photostable Nanoscopy for Single Live Cell Imaging
Single cells are building-block of all living organisms. Different types of cells express trace amounts of
distinctive sets of receptors, which can serve as biomarkers for cell identification and for disease
diagnosis. Notably, cell populations often exhibit high heterogeneity. Rare subsets of single live cells can
act distinctively and they can affect and alter functions of an entire cell population over time. Thus, it is
vital to develop new tools that can map the heterogeneity of a cell population at single cell resolution in
situ and with spatiotemporal resolutions over time, in order to understand the functions of rare subsets of
single cells and their communications with neighboring cells, and how they evolve from healthy states to
pathological states over time. Current methods (flow cytometry, genetic analysis methods and
fluorescence-based imaging and assays including high-content screening, HCS) that are used to identify
specific single live cells cannot offer sufficient photostability, multiplexing capability, selectivity, single
molecule sensitivity, temporal and spatial resolutions to specifically study individual receptor molecules
on single live cells at its native environments and characterize their functions in situ and over a long
period of time (days). Rare subsets of single cells often need to be isolated or pre-concentrated for
further analysis, which loses the opportunity to study them continuously in its native environments over
time. We propose to develop multicolored multifunctional photostable single-molecule nanoparticle
optical biosensors (m2-SMNOBS) and far-field multiplexing quantitative photostable optical nanoscopy
(mq-PHOTON) for quantitatively imaging of multiple receptors on single live cells, aiming to identify
single live cells, especially rare subsets of single live cells (≤ 5%) in highly heterogeneous cell
populations and study their functions in the cell population in situ over time with spatiotemporal
resolutions. To demonstrate unique capabilities of these new tools, as a proof-of-concept, we will use
these new tools to detect single brain cancer stem cells (bCSCs) in highly heterogeneous brain tumor
cells and study their differentiation in their native environment over time (48 hours) with spatiotemporal
resolutions. The outcomes of the proposed research include the development of highly innovative tools
for molecular identification and characterization of functions of rare and vital subsets of single live cells in
highly heterogeneous cell populations with spatiotemporal resolutions in situ in real time at single
molecule resolution. These powerful new tools will become extremely valuable to address a wide range
of pressing biochemical and biomedical questions about molecular and real-time characterization of
functions of single receptors and biomarkers on single live cells in situ over time.

Public health relevance
Statement of Health Relevance The proposed study will lead to the development of new imaging tools to advance biomedical research, including specific detection of rare subsets of single live cells in a cell population as biomarkers for early disease diagnosis. Thus, the proposed project is health relevant and highly significant.